COMPARATIVE STUDY OF ANTIRETROVIRAL THERAPY IN CHILDREN AND ADOLESCENTS

The purpose of this study is to determine whether combination antiretroviral therapy can durably reduce viral load and rpevent the emergence of multidrug resistance. This study will also assess whether viral parameters can be correlated with clinical disease progression.